Optimizing Neuroprotective Strategies for HIE in Low- and Middle-Resource Settings (LMIC neuroprotection)

PROJECT SUMMARY
Perinatal asphyxia and subsequent acute hypoxic-ischemic encephalopathy (HIE) affects 1.3-4.7/1000 liveborn
infants in the US, with the rate at least 2-3-fold higher in low- and middle-income countries (LMICs). Without
treatment, two thirds of affected infants die or develop severe neurodevelopmental impairments including
intellectual disability, cerebral palsy and epilepsy. Therapeutic hypothermia (TH) has been the standard of care
for infants with moderate or severe HIE since 2010; however, the use of TH outside of the high resource setting
is not warranted and may be deleterious. As the greatest burden of HIE is in countries that do not have access
to the facilities or patient population suitable to provision of TH, finding appropriate therapies for HIE in LMICs is
critical. Important differences in the LMIC patient population include evidence of more chronic hypoxia-ischemia
(HI), earlier neonatal seizures, and a higher prevalence of poor nutrition. These conditions result in a shift of
injury from the deep grey matter to the white matter, but are generally not modeled in preclinical HIE research.
To screen and test for LMIC-relevant neuroprotective agents, we have developed complementary in vitro and in
vivo models in the developing ferret. Our data in the inflammation sensitized hypoxic-ischemic-hyperoxic (HIH)
ferret model of HIE shows injury patterns and behavioral changes consistent with a greater white matter injury
that responds to pharmacological neuroprotectants such as erythropoietin (Epo), but not TH. In cultured
organotypic ferret brain slices exposed to simulated nutrient deprivation and intermittent oxygen-glucose
deprivation (iOGD), we have also shown similar injury patterns, with the white matter being particularly
susceptible to nutrient deprivation. We also see region-dependent responses to multiple therapies, suggesting
that an optimal therapeutic approach will require combinatorial therapies to provide global neuroprotection and
improve long-term outcomes. Building on our preliminary findings, the objectives of our proposed research are
to (1) determine the regional specificity and efficacy of multiple promising neurotherapeutic combinations in the
in vitro iOGD slice culture model with nutrient deprivation, (2) evaluate dose-dependent treatment interactions
and transcriptomic responses to established and novel neurotherapeutic combinations to optimize white matter
neuroprotection in vitro, and (3) develop a cocktail of neurotherapeutics optimizing neuroprotection in vivo in the
ferret HIH model using ferret-specific physiologically-based pharmacokinetic models. All the included
therapeutics are cost-effective, shelf-stable, and do not require specialist equipment to administer or monitor.
Our overarching hypotheses are that: (1) neurotherapeutics that provide complementary region-specific
neuroprotection in vitro will increase global neuroprotection in vivo, and (2) that compared to monotherapy,
combining complementary neurotherapeutics will result in greater neuroprotection across the entire brain that
persists into adolescence. Data resulting from this proposal could support a clinical trial in this population for
which no specific neuroprotective therapies are currently available.

Public health relevance
PROJECT NARRATIVE Perinatal asphyxia and subsequent acute hypoxic-ischemic encephalopathy (HIE) affect as many as 1% of liveborn infants and is ranked first among leading causes of disability-adjusted life years among children under 5 globally, with the majority occurring in low- and middle-income countries (LMICs). There are currently no neuroprotective interventions for infants with HIE in LMICs, and mounting evidence suggests that multiple therapies may be needed to see robust global neuroprotection. In this proposal, we describe a pipeline of LMIC- tailored in vitro and in vivo models in the ferret to screen and test combinations of therapies with the greatest likelihood of translation to HIE in the LMIC setting.